MUFA-SIRT1 signaling as a central node regulating healthspan

PROJECT SUMMARY
Macronutrients serve a multitude of roles beyond provision of energy, with numerous nutrients and/or their
downstream metabolites acting as signaling molecules to coordinate cellular metabolism and function. Indeed,
numerous nutrient sensing pathways (e.g. mTOR, AMPK and sirtuins) have evolved allowing us to respond to
specific nutrients/metabolites, which in turn impacts healthspan. Sirtuins are largely thought to be driven by
redox, whereby high levels of NAD, a cofactor in the sirtuin reaction and indicator of low energy charge, drives
sirtuin-catalyzed deacylation of target proteins. SIRT1, the most-studied sirtuin, is a key nutrient sensing node
that regulates a plethora of cellular functions to promote lifespan extension and healthy aging. As a result,
there is immense interest in the use of SIRT1 activating compounds (STACs) to prevent or treat a wide range
of aging-related disease. The links between dietary macronutrients, nutrient sensing and healthspan have
historically focused upon caloric or protein restriction with limited attention given to dietary lipids. However, a
small and growing body of literature has linked monounsaturated fatty acids (MUFAs) to improved healthspan.
In addition to positive effects on lifespan and healthy aging in model organisms, dietary MUFAs have been
linked to wide-ranging health benefits in epidemiological studies and, since they are a primary constituent of
olive oil, thought to contribute to the benefits of the Mediterranean Diet. Despite these studies, little is known
about the biological underpinnings through which MUFAs elicit their beneficial health effects. We have
previously shown that lipid droplet catabolism (i.e. lipolysis) increases SIRT1 and downstream PGC-1a/PPAR-
a signaling as a means to increase mitochondrial biogenesis and function during times of nutrient deprivation.
Our preliminary data show for the first time that MUFAs released specifically from lipolysis are trafficked to the
nucleus where they allosterically activate SIRT1 towards select acetylated peptide substrates. This discovery
makes MUFAs the first-known endogenous allosteric activators of SIRT1. Moreover, we show that MUFAs
activate SIRT1 through a similar mechanism to resveratrol suggesting that MUFA signaling may modulate the
response to exogenous SIRT1 activators. Based on these preliminary data, the objective of this application is
to further characterize the role of MUFAs as endogenous SIRT1 activators. We hypothesize that MUFAs
selectively activate SIRT1 to modulate the response to numerous dietary interventions known to impact
healthspan. To test our objective, we propose the following aims: Aim 1: To define how MUFAs modulate
SIRT1 substrate selectivity. Aim 2: To characterize the SIRT1-dependent effects of MUFAs/olive oil on
healthspan. Aim 3: To determine the contribution of MUFAs in mediating the response to STACs or caloric
restriction. Upon completion of the proposes studies, we will have further expanded our understanding of
SIRT1 biology allowing for refined approaches to activate SIRT1 to promote healthy aging.

Public health relevance
NARRATIVE The proposed studies will advance our understanding into the underlying biology linking dietary factors to healthspan. The data gleaned from these studies will help refine therapeutic or nutritional avenues to modulate lifespan and aging-related diseases resulting in a direct, positive impact on human health.